Administrative Core

Administrative Core. Core responsible for providing coordination and support of all distributed activities Dr. Berger provides unparalleled scientific and administrative leadership that will be invaluable in directing the daily activities of the Core. He will provide day-to-day operational leadership for the Administrative Core and have overall responsibility for implementing the Developmental Research Program.